Generation of Tissue Engineered Nerve Grafts from GalSafe Porcine Neurons

PROJECT SUMMARY
Tissue engineered medical products have tremendous promise to address the currently irreparable effects of
neurotrauma and/or neurodegenerative diseases. Axonova Medical’s lead product, the tissue engineered nerve
graft (TENG), is a bioactive “living scaffold” proven to promote rapid nerve regeneration and functional restoration
when implanted to repair major peripheral nerve injury (PNI). Implementing living neuronal cells as the starting
biomass, Axonova routinely biomanufactures TENGs comprised of living, long, aligned axon tracts through the
proprietary process of axon “stretch-growth”. To date, TENGs have been shown to consistently promote host
axon regeneration and improve functional recovery compared to current clinical practices in both small and large
animal models of PNI, including the repair of 5 cm segmental defects. In order to move to a manufacturing-
compliant biomass, Axonova has partnered with Revivicor to generate GalSafe® TENGs using their genetically
engineered porcine neurons to mitigate a host immune response upon eventual transplantation in humans.
Through the Phase I efforts, GalSafe® TENGs were successfully stretch-grown to create products at lengths of
1 cm, 3 cm, and 5 cm with a health and axon density that met or exceeded established quality benchmarks.
Moreover, 1 cm TENGs were transplanted into a rodent PNI model to demonstrate regenerative efficacy,
revealing that GalSafe® TENGs survived as well as actively drove host axonal regeneration via the proprietary
mechanism-of-action of TENGs, referred to as axon facilitated axon regeneration (AFAR). Along with choosing
a safe and readily available starting biomass, other product development challenges include biopreservation and
quality assurance criteria to allow increased shelf life, transportation, and maintained efficacy of the product.
Accordingly, the current Phase II SBIR program addresses a key facet of clinical grade biomanufacturing,
specifically the validation of an effective storage protocol and release criteria ensuring product health, sterility,
and potency. TENGs will be biofabricated from a cGMP-compliant cell source (GalSafe® porcine neurons), cold-
stored using a cGMP-compliant preservation protocol, and then tested in small and large animal models of PNI
to demonstrate regenerative efficacy. Specifically, Axonova will systematically complete the objectives of this
program across 3 Specific Aims: (1) determine the efficacy of fresh GalSafe® TENGs in an established porcine
PNI model; (2) effectively biopreserve GalSafe® TENGs to increase shelf-life and validate non-invasive release
criteria; and (3) determine the potency and efficacy of biopreserved GalSafe® TENGs in vivo in rodent and
porcine PNI models. This program addresses a major challenge in the translation of next-generation tissue
engineered medical products by validating manufacturing, storage and release criteria for a living biological
product to enable eventual testing in humans. The ability to store and distribute GalSafe® TENGs as an “off-the-
shelf” product will vastly increase commercial potential by reducing costs and expanding patient access, thereby
improving recovery and quality of life for patients suffering from the debilitating effects of major PNI.

Public health relevance
NARRATIVE Axonova Medical’s lead product, the tissue engineered nerve graft (TENG), is a bioactive “living scaffold” proven to promote rapid nerve regeneration and functional restoration in challenging large animal models of peripheral nerve injury (PNI). This Phase II SBIR addresses a key facet of clinical grade biomanufacturing – specifically the validation of an effective storage protocol and release criteria ensuring product health, sterility, and potency – where TENGs will be biofabricated from a cGMP-compliant cell source, cold-stored using a cGMP-compliant preservation protocol, and then tested in a large animal model of PNI to demonstrate regenerative efficacy. This program addresses a major challenge in the translation of next-generation tissue engineered medical products by validating storage and release criteria for a living biological product – necessary for eventual testing in humans – and enabling the ability to store and distribute TENGs as an “off- the-shelf” product that will increase commercial potential by reducing costs and expanding patient access.